LEARRN: Pilot Studies Component

PROJECT SUMMARY
The Pilot Studies Component identifies, supports and advances high quality, state-of-the-art proposals to
promote awardees’ competitive applications for federally funded, priority LHS rehabilitation research. The
specific aims of the Pilot Studies Program are to: 1) solicit, review, and fund meritorious applications essential
for generating preliminary data to support long-term funding streams in the development and advancement of
innovative rehabilitation practices and 2) provide early, frequent and continuous scientific and practice-driven
mentoring and administrative oversight to pilot awardees to ensure their long-term sustainable funding. We will
elicit and fund pilot studies from rehabilitation investigators across the country, enabling them to obtain
preliminary data, technical skills and the guidance needed to design, evaluate and implement learning health
systems (LHS) research projects. Selection of pilot studies for funding will emphasize projects that have high
relevance to the LeaRRN’s theme(s) and give preference to investigators outside of the LeaRRN’s home
institutions to broaden and deepen the network of independent researchers. The pilot grant review process will
not only focus on the novelty and quality of the research and investigator, but also on its practical implications
in hastening the translation of evidence into practice (i.e. significance) within the learning health system and
the investigators’ likelihood of garnering further federal funding (i.e. sustainability). We will follow a rigorous
stakeholder engaged process to identify questions and topics of high priority to health systems, pair the most
promising applicants with mentors and health systems to develop proposals that target these priorities and
solicit letters of intent. The Stakeholder engagement activities early in the project period, as well as annually
thereafter, will deliver a list of high priority questions and topics. From this list, we will connect suitable
researchers and learning health systems to address specific questions under a priority area and support their
development of the pilot grant application. The LeaRRN Executive Committee will select the most meritorious
proposals through an NIH-style, rigorous peer review. For funded pilots we will track progress through six
month and 12 month progress reports to ensure successful launch, ensure safety and protection of human
subjects and mediate potential challenges or pitfalls in time to redirect the project to a successful end. We will
track all deliverables counted as presentations, publications and subsequent funding and evaluate whether the
LHS successfully adopted or modified practice as a result of this collaboration. We have identified one pilot
study to be funded in this first year of the award to ensure a quick and effective start to our work. Drs. Theresa
Shireman and Linda Resnik will oversee the Pilot Studies Program. The mentored Pilot Studies Program is a
vital testing ground for talented researchers to work directly with health systems and mentors to fine tune LHS
rehabilitation research projects. Small, early successes strengthen skills and knowledge and will lead to better
targeted research proposals for future innovation in rehabilitation research.